Tennessee CFAR: Implementation of Culturally Responsive Trauma-Informed Care with Youth with HIV in Memphis, TN

PROJECT SUMMARY/ABSTRACT
We will accelerate health equity among underserved Black youth in a region with the third highest HIV
incidence nationally. Shelby County, Tennessee (TN; Memphis) is a Phase I priority jurisdiction for the U.S.
Ending the HIV Epidemic (EHE) initiative, where Black youth with HIV (BYWH) suffer comparatively worse HIV
outcomes: half of all BYWH in Memphis are appointment non-adherent, representing a major threat to HIV viral
suppression, morbidity, and disease transmission. Psychological trauma is a critical and understudied
mechanism driving a multitude of HIV-related disparities that will only be eliminated through multi-level
solutions. YWH endure high rates of post-traumatic stress disorder (47%), with racial trauma intensifying
experiences among Black youth. Trauma-Informed care (TIC) is an evidence-based approach that improves
patient outcomes by ensuring personnel are adequately trained to Recognize and Respond to trauma and
Resist Re-traumatization. Though the Memphis EHE plan cites TIC implementation as critical to advancing
local goals, the HIV clinic at St. Jude Children’s Research Hospital (SJCRH), primary care provider for BYWH
in the area, has not implemented TIC. We have developed this proposal with SJCRH to support enhanced TIC
for youth with HIV (TIC-YH) implementation in their HIV care clinic system. We will conduct a Sequential
Transformative Mixed Methods design study through the following two aims: 1) Implement and assess impact
of novel TIC-YH on patient effectiveness outcomes of HIV appointment adherence and trauma response and
2) Assess impact of novel TIC-YH intervention on implementation outcomes, including acceptability, feasibility,
and perceived quality of research. This innovative and highly significant research is wholly consistent with NIH
high priority area of research to reduce health disparities in treatment outcomes of those living with HIV. By the
end of the 2-year grant period, the early-stage investigator PI will have development of a programmatic line of
research to advance EHE goals and prepared a R-level grant to support the scale out of the multi-level and
culturally responsive TIC-YH intervention. There is strong rationale to support the current TIC-YH intervention
and proposed research methods as meaningful approaches to addressing disparities across a wide range of
areas, including chronic diseases.

Public health relevance
PROJECT NARRATIVE Enhanced interventions are needed to mitigate the impact psychological trauma has on HIV appointment adherence among Black youth with HIV in the Southern United States (U.S.). We will adapt and test an HIV- trauma treatment to improve outcomes for both youth with HIV and their HIV care providers in the priority region of Memphis, TN, which houses the third highest rate of new HIV infections, with a third among youth. Proposed research activities will lay the foundation for future R-level funding and support a promising early-stage HIV researcher to progress career development goals.